Administration Core

Abstract
The goal of the Administration Core is to ensure that the Projects are able to achieve their scientific and
dissemination objectives while in parallel foster synergy and overseeing interactions between the Projects to
ensure effective and coherent operation. Our central scientific and organizational leadership will rest with the
Internal Advisory Committee (IAC). The Team Director (TD) Anna Devor will oversee IAC, provide overall
scientific leadership and guidance, manage the sharing and dissemination efforts, and be assisted on a daily
basis by administrative assistant (AA) Parya Farzam to achieve the goal of the Administration Core. For grants
management including financials, progress reporting, and purchasing, the U19 team will work with their
existing respective infrastructure at Boston University (BU), University of California San Diego (UCSD),
Massachusetts General Hospital (MGH) and University of Illinois Chicago (UIC). This allows the Administration
Core to focus on the administrative tasks specific to research activities of this U19.
The Core, physically located at BU (the applicant institution), will implement the governance plan, put forward
by the IAC and offer any course corrections to IAC if needed. In addition, we will establish a to-be-named
External Advisory Board to be convened annually to assess progress and accomplishments, and to provide
guidance and direction to the team (IAC). The TD and the AA will prepare the annual progress report, maintain
a list of publications, presentations, other research products, and intellectual property that have resulted from
this U19 funding. The Core will evaluate and maintain all materials transfer agreements and other legal
agreements and activities related to sharing and dissemination that arise during the course of this program.
The Core will maintain the IACUC and IRB approvals for the U19, including updating approvals and continuing
review documents from the subcontract institution.
Our sharing and dissemination plan is extensively described within the Data Science Core. The lead of the
Data Science Core Dr. Freund will have primary responsibility over these operations and will be assisted by the
Administration Core. Progress on fulfilling the goals of the sharing and dissemination plan will be reviewed at
the monthly IAC meetings to identify any issues that may need attention and also to identify new opportunities
and needs to broaden these activities.